Embryonic Stem Cell Core

The Embryonic Stem Cell (ESC) Core is responsible for: • Creating and providing state-of-the-art reagents for the production of targeted mutations in murine embryonic stem cells. • Creating and maintaining quality-controlled embryonic stem cell lines from a variety of mouse backgrounds. • Teaching the methodology of embryonic stem cell culture and manipulation. The ESC Core provides consultative services for Siteman Cancer Center members when they are designing knock-out or knock-in vectors, and it creates and distributes user-friendly plasmids that facilitate the generation of targeting vectors. By providing a comprehensive service, the ESC Core facilitates the production of gain-offunction and loss-of-function mouse models for Siteman Cancer Center faculty.

Public health relevance
This core assists investigators in the Cancer Center with the generation of reagents used to make sophisticated mouse models of human diseases, including cancer. These reagents help us to understand how individual genes work, and how mutations work to cause cancer.